Mechanisms of Primary Cilium Assembly and Disassembly

PROJECT SUMMARY
Cilia protrude from the surface of most cells in the human body and can be traced to the last eukaryotic
common ancestor. Despite their near ubiquity, the functions of non-motile primary cilia were largely unknown
until two foundational discoveries: first, select signaling pathways depend upon and localize to primary cilia, and
second, inherited ciliary defects underlie pediatric syndromes that are now recognized as ciliopathies. These
findings revealed the importance of primary cilia but also highlighted critical gaps in our understanding. Key
questions include: how are cilia assembled, maintained, and disassembled; how do cilia promote signaling; how
is cilium disassembly linked to the cell cycle; how are ciliary functions regulated in a cell type- and tissue-specific
manner; and how do ciliary defects contribute to disease? At present, many ciliary regulators have yet to be
identified or characterized in detail, and thus the answers to these questions remain elusive.
The long-term goal of my research program is to understand the molecular mechanisms that underlie
mammalian primary cilium function. We further aim to elucidate how ciliary functions are connected to other
cellular processes and structures, including the cell cycle that governs cilium formation and the centrosome on
which the cilium is built. Lastly, we seek to identify how ciliary defects contribute to disease, with the hope that
such information can improve understanding, diagnosis, and treatment of associated pathologies.
To achieve these goals, we combine our unique expertise in genome-wide functional screening with
innovative biochemical and microscopy methods. Recently, we have conducted genome-wide CRISPR-based
loss-of-function and gain-of-function screens to systematically identify positive and negative regulators of ciliary
signaling, respectively. We further demonstrated the value of these approaches by establishing screen hits as
new ciliary regulators, including Rab34 as a mediator of ciliogenesis, Ppp2r3c as a centriolar phosphatase
subunit, and Sarm1 as part of a novel pathway for cilia disassembly. Additionally, these studies have provided
new insights into the roles of ciliary and centriolar defects in disease. We now propose to build on these efforts
through: 1) functional analysis of a newly identified pathway that mediates cell cycle-regulated cilia disassembly,
2) mechanistic studies on novel regulators of cilia biogenesis, including a transmembrane microprotein we find
to be essential for ciliogenesis, 3) development of microscopy-based screening tools for high-throughput
identification of ciliary regulators, and 4) application of these tools across diverse cell types and ciliary processes
for systematic molecular analysis of primary cilium function.
Taken together, this project aims to provide fundamental insights into primary cilia that will broaden our
understanding of the cell cycle, protein trafficking, signal transduction, and organelle biogenesis. Additionally,
these studies will help to reveal how ciliary defects contribute to disease. Lastly, the functional genomic tools
developed here are anticipated to have broad utility to the cell biology community.

Public health relevance
PROJECT NARRATIVE The primary cilium is an antenna-like cellular protrusion that allows cells to respond to external signals that instruct cell growth, differentiation, and proliferation. Aberrant ciliary signaling causes pediatric syndromes and can promote cancer development, while imbalances in cilium assembly versus disassembly are commonly observed in tumors and may contribute to uncontrolled cell growth. This proposal aims to improve our understanding of the roles of primary cilia in health and disease by elucidating the molecular pathways that underlie cilium formation, function, and disassembly.